GM/CA@APS Equipment Supplement Upgrades

These beamlines are a valuable resource for the protein crystallography community and are made available on a peer-reviewed basis. Dr. Robert Fischetti is responsible for the operation of these beamlines: Dr. Janet Smith is Director of the facility. The equipment upgrades will ensure uninterrupted availability of these beamlines for protein crystallography users at these beamlines. After nearly 15 years of full time operation, replacement of old and outdated equipment is required. Operation support of this facility has been flat for the past several years and does not include replacement equipment. The user community makes productive use of these beamlines for macromolecular x-ray structure determination and the current funding request will enhance availability of this resource for the user community.